Defining the metabolic regulation of erythropoiesis

PROJECT SUMMARY
The metabolic state of hematopoietic stem cells is an important contributor to self-renewal, however the
metabolic changes controlling the differentiation of hematopoietic stem cells to erythrocytes is poorly
understood. Here, I show preliminary data that that the malate-aspartate shuttle (MAS) impacts early
erythropoiesis. The MAS is a well-studied mechanism in cells that transfers electrons in the form of NADH from
the cytosol into the mitochondria, Specifically, disruption of the shuttle in vivo through conditional deletion of
one its enzyme in an erythroid progenitor leads to significant anemia. Accordingly, I hypothesize that the MAS
is required for redox homeostasis during early erythroid development and that failure of the MAS paves way for
ineffective erythropoiesis. AIM I works to determine which erythroid differentiation stages requires the MAS.
AIM II defines the molecular mechanism by which the MAS impacts erythropoiesis. For these, I am using both
in vivo mouse models and in vitro CD34+ hematopoietic stem and progenitor cells. Together, these aims
investigate whether reductive stress through the MAS during early erythropoiesis is an important contributor to
ineffective erythropoiesis.

Public health relevance
PROJECT NARRATIVE Diseases of ineffective erythropoiesis are characterized by dysfunctional progenitor cells that lead to decreased output of functional RBCs and, consequently, anemia. The emergence of effective metabolite therapies, such as L-glutamine for sickle cell disease, highlight the potential of metabolic inputs of erythropoiesis to develop targeted therapies. The goal of this proposal is to elucidate the mechanism by which redox balance through the malate-aspartate shuttle affects red blood cell development.